Understanding the Role of kB Ras Proteins in Signaling and Development

DESCRIPTION (provided by applicant): The goal of this project is to understand how κB-Ras1 and κB-Ras2, members of an unusual sub-class of Ras-like proteins, are regulated, and how they in turn regulate pathways leading to NF-κB and Ral GTPases. These proteins were originally discovered through their physical interaction with the IκBß protein, and in vitro and overexpression experiments indicated that they are inhibitors of NF-κB. However the true physiological role of these proteins has remained unclear. Our preliminary results using knock-outs of both κB-ras genes shows that they act to inhibit both NF-κB and Ral GTPase pathways. Interestingly, mice lacking κB-Ras proteins also die perinatally due to defects in lung development. In this research proposal we aim to ask the following questions. In Aim 1 we will study how κB-Ras actually regulates NF-κB. While affecting the stability of IκBß is a likely mechanism, many questions about exactly how κB-Ras functions remains unanswered. Availability of cells lacking κB-Ras will allow us to explore the underlying mechanism in a systematic manner. We will also use mice lacking κB-Ras in macrophages to study mouse models of inflammation including septic shock and collagen-induced arthritis. In Aim 2 we will ask how κB-Ras regulates Ral, and determine whether activated Ral contributes to NF-κB activation. We will study the mechanism by which growth factor signaling disrupts the κB-Ras-RalGAP complex, and determine why binding to κB-Ras inhibits the activity of RalGAP. We will also test whether the activated Ral in κB-Ras deficient cells contributes to NF-κB activation. Finally in Aim 3 we will explore the lung phenotype seen in the κB-Ras-deficient animals. We will study the mechanism of dysregulated surfactant expression, in particular the role of NF-κB in the process. In summary these studies will provide significant new insight into the biology of these evolutionarily conserved, yet enigmatic, members of this Ras-like family of proteins.

Public health relevance
Chronic inflammation underlies many diseases such as arthritis, asthma and cancer. The transcription factor NF-κB plays a key role in regulating inflammation and understanding the molecular mechanism that regulates NF-κB is of great interest. In this proposal we will determine how κB-ras proteins regulate the activity of NF-κB and Ral GTPases, and determine why lack of κB-Ras leads to defects in lung development.